The Ability of MRI to Detect Adverse Local Tissue Reaction and Implant Integration as a Function of Hip Implant Modularity

Project Summary
Total hip arthroplasty (THA) has been successful in achieving pain reduction, but recent concerns have been
raised regarding the development of adverse local tissue reactions (ALTRs). Our previous application focused
on utilizing MRI as a noninvasive biomarker of ALTR, so that appropriate intervention can be recommended
before extensive damage occurs. By evaluating THAs of different bearing materials we found: 1) MRI can detect
and distinguish wear debris from THA; 2) MRI is sensitive to ALTR damage from different articulating
surfaces; and 3) variable host-mediated response to wear debris mounts distinct morphologic patterns on MRI.
There is continued interest in the evaluation of soft tissues near THAs as traditional THA designs, including
metal-on-polyethylene (MOP) and ceramic-on-polyethylene (COP) bearing surfaces, have recently been
implicated in ALTRs. It is believed that fretting and corrosion at the head-neck junction is responsible for
ALTRs, secondary to flexural rigidity and other implant mechanical features. If a greater prevalence of ALTR is
found in components with more flexible connections, this could drive the practice of THA to stiffer
connections.
In this renewal application, we will evaluate two important causes of implant failure: (1) in designs not
traditionally associated with ALTRs such as metal-on-polyethylene (MOP) and ceramic-on-polyethylene (COP)
we will assess patients indicated for revision THA surgery with MRI and correlate the imaging metrics to
targeted biopsy retrieval obtained at the time of revision (including the trunnion), the extent of tissue damage
documented at surgery, and implant retrieval analysis of the neck trunnion, including flexural rigidity analysis;
and (2) to longitudinally assess implant integration using qualitative MRI evaluation of the bone-implant
interface as well as quantitative MRI techniques, T2 mapping and T2* mapping using MAVRIC-UTE, to
evaluate relaxometry at the interface.

Public health relevance
Project Narrative Patients with a total hip replacement may require early revision surgery due to an adverse local tissue reaction or bone resorption that occurs due to wear debris released from the implant. MRI provides a non-invasive biomarker for clinicians and surgeons to detect early adverse synovial reactions which may exist in the absence of clinical symptoms, thus imparting essential information for clinical management. This proposal will address two of the most commons causes of hip implant failure, including adverse local tissue reaction in implants not traditionally associated with adverse tissue reactions, as well as the presence of aseptic loosening and loss of implant-bone integration.